Platelets in radiation-induced immune dysregulation

RESEARCH SUMMARY
In a large-scale nuclear event, many people could be exposed to high doses of ionizing radiation (IR). This can
have long-term adverse effects on immune function, putting victims at risk for immune disorders and contributing
to the dysfunction of organs that depend on a functional immune system. Currently no FDA-approved drugs are
available to mitigate immune dysregulation in radiation victims. The overall objectives of this project are to
understand how platelets contribute to immune dysregulation after exposure to IR and to test platelet-centric
countermeasures to mitigate IR-induced immune dysregulation and organ damage (specifically in the intestine
and heart). Platelets can regulate immune function by binding directly to immune cells or by delivering submicron
platelet-derived microparticles (PMPs) to the cells. In every healthy individual, platelets form platelet–leukocyte
aggregates and generate PMPs in the circulation under normal conditions, but these activities increase under
pathological conditions. Various platelet receptors interact with their specific counter receptors on leukocytes,
specifically polymorphonuclear neutrophils (PMNs) and monocytes—2 crucial members of the innate immune
system that can modify the adaptive immune response—to form platelet–leukocyte aggregates. Central to this
interaction is platelet glycoprotein Ibα (GPIbα) binding to leukocyte Mac-1, resulting in activation of both platelets
and leukocytes. PMPs can activate PMNs and monocytes by delivering cytokines, growth factors, and RNA.
Notably, proteolytic cleavage of platelet GPVI is an essential step for PMP generation. Our preliminary data show
that mice with dysfunctional GPIbα (cannot bind Mac-1) exhibit increased inflammation, intestinal injury, PMP
generation, and lethality following a single dose of 8.5 Gy total-body irradiation (TBI) compared to wild-type mice.
Moreover, we showed that mice with dysfunctional GPIbα are more prone to inflammation following polymicrobial
sepsis, which can occur after IR exposure. Finally, GPVI-KO mice generate fewer PMPs and exhibit reduced
plasma pro-inflammatory cytokine levels compared to mice with dysfunctional GPIbα after 8.5 Gy TBI. We
hypothesize that lack of GPIbα–Mac-1 interaction and enhanced PMP generation contribute to IR-induced
immune dysregulation and predict that administering exogenous GPIbα or limiting PMP generation will mitigate
IR-induced immune dysregulation and organ damage. The studies outlined in this proposal will: 1) Determine
whether selective blocking of GPIbα binding to Mac-1 exacerbates, while exogenous GPIbα administration
mitigates, TBI-induced immune dysregulation and 2) Evaluate whether limiting PMP generation by inhibiting
GPVI mitigates TBI-induced immune dysregulation. Our studies will provide insight into the previously
unexplored role of platelet–leukocyte interaction and PMP generation in modulating IR-induced immune
dysregulation. Most importantly, the findings will help to develop novel radiation mitigators.

Public health relevance
PROJECT NARRATIVE Victims of a nuclear event can be exposed to ionizing radiation, which has long-term adverse effects on their immune system. This application will investigate 2 mechanisms of radiation-induced immune dysregulation: 1) the interaction between platelet receptor glycoprotein Ibα (GPIbα) and leukocyte Mac-1 and 2) the production of platelet-derived microparticles (PMPs). We will test whether exogenous administration of GPIbα and blocking PMP production are viable strategies to mitigate the adverse effects of ionizing radiation.